Effectiveness of Concurrent Care to Improve Pediatric and Family Outcomes at End of Life

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
This grant proposal represents a first competitive renewal (Cycle 2) of a highly productive, NINR-funded research program investigating a health policy intervention for children and adolescents with serious illness. The Cycle 1 research question was whether pediatric concurrent care (simultaneous hospice and medical care) affected pediatric and family outcomes. A significant increase in fragmented care transitions and a high risk of adverse outcomes was identified, along with a cohort of rural children and adolescents significantly affected by this care environment. In response, Medicaid programs in several states ushered in transitional care regulations (TCR) for pediatric concurrent care that mandated collaborative team efforts from nurses, physicians, pharmacists, child life specialists, and other health care professionals to support and coordinate pediatric end-of-life care across settings during concurrent care. In Cycle 2, the proposed policy effectiveness project focuses on advancing pediatric health policy by examining this policy modification within a rural cohort. The project’s specific aims are to: (1) estimate the effect of the TCR intervention on rural children’s end-of-life health (i.e., functioning) and health care (i.e., resource use, spending); (2) identify a subgroup of at-risk rural children using innovative machine learning methods; (3) examine potential mechanisms and pathways that may inform further policy improvement strategies important to rural children and families generally and the at-risk subgroup in particular. These aims will be achieved by conducting a multi-level natural experiment with a difference-in-difference analysis, supervised and unsupervised machine learning, and mediation and moderation analysis. The project team has the expertise in pediatric concurrent care (Lindley), data science (Keim-Malpass, Cao) and statistical analysis (Cozad, Svynarenko). Practice partner includes the National Network of Pediatric Palliative Care Coalitions. The project is innovative because it advances the understudied area of policy-focused effectiveness science. The project is significant and will have an impact because it focuses on a major policy modification and because it will generate knowledge to inform rural health care for children.

Public health relevance
This Cycle 2 renewal proposal directly addresses the public health concerns for at-risk populations such as rural children and adolescents with serious illness. Its results will represent a continuation of our Cycle 1 evaluation of a health policy intervention on pediatric end-of-life outcomes and will provide evidence on the effectiveness of a policy modification (i.e., transitional care regulations) to improve functioning, resource use, and spending among children and adolescents receiving hospice and medical care simultaneously.